Project 6: Defining the Sustainable uses of Low-Arsenic Aquifers in Bangladesh

PROJECT SUMMARY (See instructions): The first goal of this project is to continue to lower the exposure to arsenic (As) of a cohort of 24,000 men and women recruited under the Health Effects of Arsenic Longitudinal Study (HEALS). This will be achieved by testing the numerous household wells that continue to be installed within the study area of Araihazar, using both laboratory measurements and field kits with support from Core C. In addition, the 110 deep community wells installed in some of the most affected portions of the study area will continue to be monitored. Beyond the ethical motivation, lowering exposure will help define exposure estimates of the studypopulation and, therefore, the dose-response relationships for various end-points studied under Projects 1, 2, and 3. The second goal of the project is to improve our understanding of the processes that threaten the quality of groundwater in aquifers that are presently low in As in Bangladesh by conducting field investigations. To determine the vulnerability of shallow (<30 m) aquifers that are tapped by most household wells, a ~1 km2 open field area located between a high-As and a low-As village of Araihazar will be densely instrumented and monitored for an entire year. Four ponds will then be dug and a nearby area raised with the fill to simulate the rural development of the region. The impact of this perturbation on the local hydrology and biogeochemistry (including As) of the perturbed areas, as well as two unperturbed controls, will be monitored for three years. To determine the vulnerability of deeper (>100 m) low-As aquifers, the origin of the failure of a handful of community wells in Araihazar will be investigated using a combination of geophysical, hydrological, and biogeochemical approaches supported under Project 4 and Cores C and D. The potential for downward incursion of shallow high-As groundwater on a broader scale due to intensive deep pumping below the city of Dhaka will be evaluated and modeled. These investigations will be carried out in the country where the health impact of As release to groundwater is by far the largest worldwide.

Public health relevance
RELEVANCE (See instructions): Untreated groundwater is the main source of human exposure to As in both the US and in Bangladesh. Private wells will continue to be used in rural areas of both countries in the future; their vulnerability is therefore a public health issue. The understanding of As adsorption and transport that will result from this research is relevant to aquifers that are naturally elevated in As as well as contaminated Superfund sites.